Modeling cancer evolution for prediction with neural networks: methods and applications

PROJECT SUMMARY/ABSTRACT
The study of tumor evolution can uncover events and interactions that drive tumor development
through alternative routes, reveal differences in therapeutic vulnerabilities and improve clinical decision
making. Yet, studying tumor evolution is challenging, hindered by the difficulty to interpret noisy genomic
data and the lack of temporal ordering of major genetic events. There is therefore a critical need for the
development of computational approaches that can facilitate efficient investigation of cancer data under
an evolutionary, temporal perspective. The long-term goal of this project is to develop computational tools
combining advanced machine learning with molecular evolution techniques and provide novel strategies
to investigate tumor evolution. The overall objective is to establish a deep-learning framework to study
tumor development that will be used to distinguish early and late genetic events that are associated with
tumor characteristics, survival and therapeutic vulnerabilities. The rationale of the proposed research is
that the study of tumor evolution through integration of machine learning with molecular evolution
techniques could enhance the performance of otherwise difficult clinical classification tasks. The specific
aims of this project are to (1) Characterize the interplay between driver mutations and aneuploidy in tumor
evolution and identify determinants of clinical outcome and therapeutic vulnerabilities (2) Introduce
computational approaches to represent snapshot genomic data through temporal and functional ordering
of genetic events (3) Develop a recurrent neural network approach to learn different dynamics in tumor
evolution from ordered genomic data, and predict phenotypic features and clinical outcome. The
proposed research is innovative because it will combine recent advances in machine learning with
evolutionary techniques into a single framework, establishing novel computational tools that will facilitate
a comprehensive investigation of cancer development. The proposed framework is significant because it
will enable application of temporal modeling with machine learning to cancer data, for prediction of clinical
features. To achieve the proposed goals the candidate, Dr. Noam Auslander, requires additional training
and mentoring in evolutionary research, comparative genomics and mathematical modeling. During the
K99 phase, Dr. Auslander will conduct this research as a postdoctoral fellow at the National Center for
Biotechnology Information. She will be mentored by Dr. Eugene Koonin, a recognized expert in the fields
of molecular evolution and computational biology, and additional mentoring from senior members from
the Koonin lab. Together with her previous training in machine learning and cancer data science, this
application for the NIH Pathway to Independence Award (K99/R00) describes a career development plan
that will allow Dr. Auslander to achieve her career goals and become an independent investigator and
leader in computational research of cancer evolution.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it entails new strategies to study cancer evolution that will uncover distinct therapeutic vulnerabilities and determinants of clinical outcome. The establishment of the proposed methodologies will offer temporal models for data representation and neural network frameworks for cancer research, that will contribute to enhancement of clinical prediction tasks. Thus, the proposed research is relevant to the part of the NLM’s mission that pertains to enhancing human intellectual capacities through dynamic modeling and machine learning strategies to improve medical decision-making.